Identification of TDP-43 Modifiers Through Single-Cell Transcriptional and Epigenomic Dissection of ALS and FTLD-MND

Abstract
Amyotrophic lateral sclerosis (ALS) and frontotemporal lobar degeneration (FTLD) are two fatal
neurodegenerative conditions with no current treatment to prevent, decelerate or stop neuronal death in
patients. ALS and FTLD are clinically distinct but show an overlap in postmortem brain pathology and genetic
factors: nuclear clearance and cytoplasmic accumulation of TDP-43 in affected central nervous system (CNS)
regions is observed in 98% of ALS and 50% of FTLD patients. While initial symptoms lead to the diagnosis of
either ALS or FTLD, up to 50% of ALS patients eventually develop symptoms of FTLD, with ~15% of patients
ultimately receiving both diagnoses (FTLD with motor neuron disease, FTLD/MND). Mutations in the gene
encoding TDP-43 (TARDBP) lead to rare cases of ALS, while TDP-43 pathology is observed in patients
carrying more prevalent mutations, such as a pathological C9orf72 hexanucleotide repeat expansion
(C9orf72+)—the most common genetic cause of ALS and FTLD identified thus far. TDP-43 therefore appears
to be a pivotal and convergent factor in the pathogenesis of both ALS and FTLD. Despite this, however, the
reasons for selective vulnerability of motor neurons, the mechanisms responsible for TDP-43 mislocalization,
and the impact on neuronal health of nuclear TDP-43 exclusion and aberrant liquid-liquid phase separation
underlying cytoplasmic demixing remain unknown. To address this challenge, in Aim 1, we systematically
profile the transcriptional and epigenomic alterations of ALS and FTLD/MND patients at single-cell resolution
using post-mortem CNS samples. In Aim 2, we integrate the resulting datasets to study the link between
genetic, epigenomic, transcriptional, and cellular signatures of ALS and FTLD/MND. We associate these links
with available clinical information, elucidate the genes and biological pathways altered in each, and predict new
therapeutic targets. In Aim 3, we validate the molecular and cellular effects of these targets by assessing their
impact on neuronal viability and TDP-43 functions/aggregation using high-throughput directed perturbation
experiments. We study both cell-autonomous and non-cell-autonomous effects of these perturbations in
human dura fibroblast-derived iPSC neurons and astroglia. In Aim 4, we perform neuropathological analyses
of TDP-43 modifiers in ALS and FTLD/MND postmortem tissues, and endeavor to rescue in vivo pathology and
phenotypes in a mouse model. The resulting datasets, analyses, and dura-derived iPSCs will provide an
invaluable resource to understand the mechanisms of TDP-43 pathology in ALS and FTLD/MND, and may
reveal putative therapeutic targets able to mitigate TDP-43 pathology through genetic manipulation.

Public health relevance
Narrative Amyotrophic lateral sclerosis (ALS) and frontotemporal lobar degeneration (FTLD) are two devastating and fatal neurodegenerative disorders that are clinically distinct but show an overlap in genetic factors and central nervous system (CNS) neuropathology in the form of cytoplasmic TDP-43 depositions, but the mechanistic basis of their shared and distinct circuitry remains unknown at the molecular level, preventing the identification of needed therapeutic targets. Here, we use single-cell high-resolution profiling of epigenomic and transcriptional alterations in post-mortem CNS samples from ALS and FTLD with motor neuron disease (FTLD/MND) patients to elucidate their underlying mechanism of action, shed light on their common and distinct circuitry, and identify genetic and cellular factors that drive TDP-43 neuropathology and corresponding neurotoxicity, using patient derived cells and in vivo model systems. This ambitious proposal has the potential to (a) provide mechanistic insights into the development of ALS and FTLD/MND, (b) identify genetic modifiers of TDP-43 pathobiology, and (c) reveal functional risk variants and target genes for therapeutic intervention using gene modifying therapies.